Montana Tech Training Project Grant Application

Project Summary
Montana Technological University, formerly known as Montana Tech of the University of
Montana, is commonly referred to as “Montana Tech” and will be denoted as such
throughout this proposal narrative.
This proposal is for a single TPG with three closely related degree programs:
1. B.S. in Occupational Safety and Health
2. M.S. in Industrial Hygiene (referred herein as MS IH Campus Program)
3. M.S. in Industrial Hygiene Distance Learning/Professional Track (referred herein
as MS IH Distance Learning Program)
The three programs have been part of our most recent TPG. In our 2012-13 application,
we counted our MS IH Distance Learning Program graduates among the total output of
the NIOSH extramural training program, but did not seek NIOSH trainee tuition support
for these students. This proposal requests NIOSH trainee support for all three
programs. The three programs are housed in the Safety, Health, and Industrial Hygiene
Department. Six faculty members in the Department are substantially involved in
teaching and research in safety, health, and IH, while one additional faculty member
provides a supporting role. In addition, one faculty member serves in a part-time role.
The undergraduate OSH curriculum provides a comprehensive education to develop
graduates with capability for serving as exceptional safety and health professionals,
while the graduate programs aim to develop exceptional IH professionals.
The OSH program and both MS IH programs are accredited by ASAC/ABET. In
addition, all three programs are designated as Qualified Academic Programs by the
Board of Certified Safety Professionals.
Nearly all graduates of the three programs take professional career positions in
occupational safety or industrial hygiene. The graduates tend to stay in the field and
spend their entire career preventing occupational injuries and diseases. While the BS
OSH and the campus MS IH programs primarily serve students in the Northwestern
U.S., the student demographics of the MS IH Distance Learning Program are
considerably different. Students in this program are working professionals who reside
throughout the U.S. These students are seeking a M.S. degree in order to enrich their
IH skills and advance professionally.

Public health relevance
Relevance to Public Health The Montana Tech Safety, Health and Industrial Hygiene Department provides high quality, accessible, science and technology curricula and research opportunities designed to prepare students for successful OSH and IH careers. This is especially relevant to our public health because the burden of occupational injuries and illnesses in the U.S. has been estimated to be similar to the burden from cancer and exceed that of AIDS, Alzheimer’s disease, and arthritis.1 Despite the tremendous burden that occupational injuries and illnesses have on our society, fewer than half of the anticipated OSH professionals needed in the U.S. are anticipated to graduate in the coming years.2 We’ve been working hard to meet this demand since our first program was established in 1975 and we continue to grow and produce more qualified graduates thanks in large part to the support of the NIOSH TPG program.